High-Resolution Lymphatic Mapping of the Upper Extremities with MRI

Project Summary
Lymphedema is a condition in which the clearance of lymph is compromised, resulting in edema and swelling of
limbs, with potentially devastating impact on quality of life and medical costs. The most common cause of
lymphedema in the US is from cancer-related surgery. Lymphedema is progressive and has no cure. It is not
known why some patients develop lymphedema while others do not. Studies of cadavers have shown that the
lymphatic anatomy can vary across individuals, and it is believed that these variations may increase the risk for
certain individuals to develop lymphedema. If this is true, steps may be taken to prevent lymphedema from
developing, for example with a bypass at the time of surgery. However, there is no practical way to obtain a
complete lymphatic anatomical map within an extremity in vivo. Current imaging techniques are limited by
penetration depth, low resolution, invasiveness, and partial coverage. The challenge is to map lymphatic
channels, with diameters of 0.4-0.8 mm, and to trace them from all regions of an extremity back to draining lymph
nodes. This proposal focuses on the development of a novel high resolution magnetic resonance (MR)
lymphography technique (hrMRL) for lymphatic mapping of the upper extremities in living people. hrMRL will be
a combination of a fast spin echo sequence with tailored variable flip angles, background subtraction, and
acceleration via undersampling with compressed sensing and deep learning. The first aim will be to construct
and optimize each of these components in an iterative fashion using phantoms, followed by testing on 10 healthy
subjects, with the goal of obtaining maps of the lymphatic channels of an entire extremity within a target time of
20 minutes, suitable for clinical adoption. In the second aim, hrMRL will first be used to obtain full lymphatic
anatomic maps of the upper extremity of 35 healthy volunteers who previously underwent indocyanine green
(ICG) lymphography, which will serve as a gold-standard reference. hrMRL will then be validated aginst ICG by
comparing both maps and determining their degree of agreement. hrMRL is also expected to resolve additional
lymphatic channels undetected by ICG, allowing us the opportunity to create more comprehensive maps and to
characterize new pathways, in particular the deep lymphatic channels. If successful, hrMRL would be
immediately impactful in the clinical setting, where it could guide measures to avoid onset of lymphedema,
shifting the lymphedema management algorithm from one of supportive and corrective therapies to one of
prevention, with the goal of reducing the incidence of this debilitating and costly disease.

Public health relevance
Project Narrative Lymphedema, which is symptomatic swelling caused by damage of the lymphatic system commonly caused by cancer treatment, can have devastating and permanent clinical and financial consequences for patients. We propose developing a noninvasive, MRI-based, clinically- translational technique that can provide anatomic maps of the lymphatic system in vivo, enabling surgeons to plan surgery to avoid lymphatic damage. If successful, this method would potentially shift the entire paradigm of lymphedema management, from a current focus on therapy to one of prevention.